Clinical Oncology Research Program (CORP)

PROJECT SUMMARY/ABSTRACT
The overall goal of the Clinical Oncology Research Career Development Program is to support the intent of the
Paul Calabresi Award for Clinical Oncology (K12). The Program fosters interdisciplinary training in clinical and
translational oncology therapeutic research for physicians in one of a number of oncology disciplines, including
medical, surgical, dermatologic, pediatric, radiation and pathology. By designing a K12 program that brings
together these broad disciplines, the Paul Calabresi Scholars themselves form a multidisciplinary group
whose collaborations and interactions augment the overall training efforts under the K12 program. Firm core
requirements include completion of required and elective course work for a Certificate in Clinical Translational
Oncology Research at Case Western Reserve University. A basic research effort is a required part of the
training program and is linked to the clinical research efforts that include writing and activating a therapeutic
clinical protocol and submission of a career development award application. These efforts will result in highly
qualified Paul Calabresi scholars capable of independent research in clinical oncology and therapeutics with a
team science orientation based in hypothesis testing of important translational questions in the field. The
Program brings together strong Internal and External Advisory Committees committed and experienced in the
area of clinical translational therapeutics research in oncology. The Program and the cancer center provides
scholars with an outstanding environment to pursue career development. Past trainees have emerged as
academic physicians developing independent clinical research programs often with external funding and with
active investigator-initiated clinical trial efforts.
!
!

Public health relevance
PROJECT NARRATIVE This mentored career development program supports physician investigators to gain skills in cancer research and clinical therapeutics that emphasizes innovative treatments and use of genomics to select proper and individualized treatments for cancer patients, increasing the likelihood that such treatment will be effective. ! !